Enhancing Nurse Practitioner Primary Care Delivery to Address Social Determinants of Health and Reduce Health Disparities: A mixed-methods national study

More than 80% of adults aged 65 and older in the United States have at least one chronic health condition. Racial and ethnic minorities suffer more. They often lack high quality care and use hospitals and emergency departments (EDs) for routine care. Where minorities reside and receive care contribute to health disparities. They often live in disadvantaged neighborhoods, and conditions of daily living lead to disparities. Minorities also get care in low quality healthcare settings. Health disparities will further widen due to primary care physician shortages. The growing nurse practitioner (NP) workforce can help reduce health disparities. Yet, practices employing NPs (i.e., NP practices) are often located in underserved communities and face major structural (e.g., lack of registries) and organizational (e.g., poor care environments) challenges. The study’s overarching aim is to understand ways in which NP practices could be leveraged to address conditions of daily living and reduce health disparities. Building on our prior work, we will conduct the first national mixed-methods study using multilevel models, geographic information system, and a positive-deviance approach to achieve the aims: Aim 1. Investigate the impact of conditions of daily living (i.e., economic stability, education, built environment, health care access, and social context) on health disparities in quality of care processes (e.g., HbA1c testing for diabetes) and outcomes (i.e., ED use, hospitalizations) among chronically older adults receiving care in NP practices). Aim 2. Assess the extent to which NP practice attributes (i.e., care environment, structural capabilities) moderate the impact of conditions of daily living on health disparities in quality of care processes and patient outcomes. Aim 3. Explore barriers and facilitators to addressing conditions of daily living and health disparities in NP practices with varying care environments and structural capabilities. We will use existing data on neighborhoods and chronically ill Medicare patients cared for by NPs in 2021-2022 in primary care practices (n=2,400). We will also survey NPs (n=6,960) in these practices on their care environments and structural capabilities using mail and online methods. All data about patients, neighborhoods, NPs, and practices will be merged and analyzed in multilevel models. We will also identify practices with favorable and unfavorable care environments and structural capabilities and interview NPs and practice managers using positive-deviance methods. We will conduct individual telephone/online interviews with ~50 NPs and ~50 practice managers from practices with favorable and ~35 NPs and ~35 managers from practices with unfavorable attributes. The interviews will be recorded and transcribed for content analysis. We will identify modifiable factors in practices to address conditions of daily living. Our quantitative and qualitative findings will be triangulated to inform administrators and policymakers seeking ways to leverage NP practices to address conditions of daily living and reduce health disparities through practice, policy, and neighborhood interventions.

Public health relevance
Addressing the conditions of daily living is key to eliminating health disparities among chronically ill elderly patients. Through a large, national, mixed-methods study, we will examine patients’ neighborhoods and primary care practices where they receive care from nurse practitioners to produce evidence to help design future interventions to improve neighborhoods and strengthen primary care practices to ensure optimal care and outcomes for all patients.